Integration of Peer Navigation and mHealth Technology to Improve Viral Suppression among Racial and Ethnic Minority PLWH in Community-Based HIV Care Clinics

PROJECT SUMMARY
Significant disparities continue to exist in the HIV care continuum in the U.S., with Hispanic and Black persons
living with HIV (HBPLH) being less likely to achieve viral suppression compared to non-Hispanic White persons
living with HIV. The same HIV treatment disparities exist in San Diego County, one of the focal counties under
the Ending the HIV Epidemic Initiative. Disparities are exacerbated by co-occurring syndemic conditions,
including substance use. Peer navigators, as one type of community health worker, have been shown to play
meaningful roles to support PLH to stay engaged in care in developing countries. More rigorous studies are
needed to evaluate the impact of peer navigators on the HIV care continuum in the U.S. While peer navigators
may promote positive outcomes among PLH, scale-up of the traditional peer navigation approach is difficult in
real-world settings where there are limited resources to support peer navigators. Scalable, mHealth intervention
approaches are needed to strengthen the impact of peers on the HIV care continuum outcomes among HBPLH.
Mobile (m)Health and other technologies offer scalable platforms for intervention delivery through channels (e.g.,
online, mobile apps, SMS, and social networking platforms) that can overcome limitations and costs of in-person
interventions. Combining both peer navigators and mHealth into a unified, scalable intervention could both
strengthen the impact of peer navigators on HIV care continuum outcomes among HBPLH, and simultaneously
reduce the resources needed to support peer navigators in clinical settings, effectively striking the ideal balance
between maximizing clinical effect sizes and lowering peer navigator costs to promote sustainability. Partnering
with a community-based clinic (San Ysidro Health, SYH) serving HBPLH under the Ryan White model in South
San Diego, we propose a two-arm RCT (n=375) of an mHealth peer navigator intervention called Peers plus
mobile App for Treatment in HIV (PATH). We will integrate two theoretically-grounded interventions developed
by this team – one with a strong peer navigator component (called “Conexiones Saludables”) and the other with
a scalable mHealth component (called “LinkPositively”)– into the PATH intervention, with the goal of amplifying
the impact of peer navigators on viral suppression among HBPLH. We will integrate, refine, and usability test
(Phase 1) these interventions into a unified, community-informed intervention, PATH, to be rigorously evaluated
in a RCT (Phase 2). We will test the efficacy of PATH with 375 HBPLH (among whom >33% will report stimulant
and/or opioid use in the past 6 months) to: 1) Improve sustained viral suppression (i.e., suppressed viral load at
both 6- and 12-month follow-up) compared to usual care; 2) Examine the theory-informed mediators (e.g., self-
efficacy to engage in HIV care, HIV stigma) through which PATH has the greatest impact on sustained viral
suppression among HBPLH; and 3) Explore whether PATH significantly affects substance-related outcomes
(e.g., frequency of substance use, engagement in substance abuse treatment) when compared to usual care
among those using substances (i.e., stimulants and/or opioids).

Public health relevance
PROJECT NARRATIVE The primary goal of this project is to address racial/ethnic disparities in the HIV care continuum by evaluating the efficacy of a novel intervention called “PATH” that integrates peer navigation with mobile health (mHealth) technology with Hispanic and Black persons living with HIV (HBPLH). We believe PATH has the potential to be an impactful, sustainable, mHealth peer navigation approach encompassing a powerful suite of theory-based components to strengthen the impact of peer navigators and reduce HIV treatment disparities among HBPLH, including among persons living with HIV with co-occurring substance use. We will partner with a community- based clinic that serves HBPLH under the Ryan White model of care in South San Diego to conduct this randomized trial.